Identifying Structural Vulnerability Latent Classes Associated with the Health Outcomes of Latino Immigrant Men in Baltimore

Recent public health events have highlighted the disproportionate burden communities of color
face in the U.S. as a result of chronic health disparities. Foreign-born immigrant Latino men
(LM) have been found to be particularly likely to engage in risky behaviors (substance use,
sexual risks) and less likely to seek out health care services when compared to Latina immigrant
women. A growing body of research has documented the impact immigration-related stressors
have on the mental health and substance use of LM. However, there is a gap in knowledge of
how psychosocial vulnerability, in the form of a complex dynamic between racial
discrimination, stigma, violence victimization and social isolation, contribute to health
disparities. Guided by structural vulnerability theory, we will use a sequential explanatory mixed
methods approach to first conduct latent class analyses to identify psychosocial vulnerability
subgroups of LM (N=300) and associations with health outcomes. Next, we will develop deeper
etiological understanding of identified latent classes by qualitatively characterizing subgroups
based on the lived experience of participants (n=40). Specifically, this study aims to 1. Identify
distinct psychosocial vulnerability (racial discrimination stigma, v iolence, social isolation) latent
classes (e.g., hypothesized high, moderate, low classes) among LM in Baltimore; 2. Examine the
individual (socio-demographics, legal status, English proficiency), and socio-contextual
determinants (social support, family contact, living and working conditions) associated with
each psychosocial vulnerability latent class (e.g., high, moderate, low), and their associations
with health outcomes (drug and alcohol related problems, infection risk, mental health); and 3.
Qualitatively characterize the influence socio-cultural contextual factors have on the distinct
psychosocial vulnerability latent classes identified in Aims 1 & 2. The proposed study will
advance scientific knowledge by elucidating the lived psychosocial and health effects of systemic
oppression among a vulnerable and significantly underserved group of immigrant men.
Successful completion of this R21 project has high promise to inform and test novel targeted
public health prevention interventions to reduce health disparity burdens among LM in a future
R01 application.

Public health relevance
Foreign born immigrant Latino men have been found to engage in risky behaviors (substance use, sexual risks) and under-utilize health care services. This application seeks to determine how psychosocial vulnerability, in the form of a complex dynamic between racial discrimination, stigma, violence and social isolation, contribute to health disparities among this population. Using a mixed methods approach, we will identify unique subgroups of psychosocial vulnerability and examine associations to health outcomes among immigrant Latino men.